Significant Life Event Supplement-Neural mechanisms of auditory plasticity and perceptual learning

19A!!!>2$$B3A3<!C!!$A4!D5E!6F$0A?!!5$!%/!"$!"!"!!12!34$5$2%!#!334!#!$6!4"!!#%$G!!!$$!!!#$!!!$!!$7$!$!!#!%!!!$&8!!!!!$'!!(!$#5$)($'!$!*24!+1%+9!!(9!4:#5!;$$<,#=->,:.!!!!?#
$$$!!!!!!$$$!!!2!!!3#24#3!4!$!!$#!$$!!!!!$#!!!$$!$!!!%!$!$!$!"!2!$3$4%$9!$!!!!!$!%9!#$#!!$$!

Public health relevance
PROJECT NARRATIVE The neural mechanisms supporting auditory perceptual learning are largely unknown. The current project addresses this issue by examining the role of one specific brain region, orbitofrontal cortex, in this process. Findings from this proposal may one day lead to the development of training or treatment regimens to facilitate language learning and musical training in both normal-hearing and hearing-impaired listeners.